Maternal alcohol exposure: impact on genetic control of craniofacial phenotype

Project Summary I am a postdoctoral fellow in the Division of Craniofacial Medicine, Department of Pediatrics, University of Washington in Seattle. My research interests lie in understanding the mechanisms (ie. contributions of genes and environmental factors) responsible for human malformations, specifically craniofacial disorders, and normal phenotypic variation. With this in mind, my goal is to exploit tomographic imaging techniques as well as geometrics morphometrics as a means to quantitatively assess craniofacial phenotypes. I apply to this K99/R00 Pathways to Independence Award with the long-term goal becoming an independent researcher in the field of craniofacial dysmorphology. I have developed a research program to augment my background in quantitative morphology and 3D digital imaging with quantitative genetics and embryology to transition myself into an independent investigator in biomedical sciences. As the first step towards this goal, I will explore the effect of gestational alcohol exposure on the embryonic and post-natal craniofacial development of mice using: (1) state-of-the-art high-resolution in-vivo microCT and optical projection tomography, (2) traditional 3D shape quantification methods and a new 3D grid deformation methodology to characterize phenotypic differences, and (3) the use of a novel mouse model of moderate dose chronic ethanol exposure that produces FAS related measurable phenotypes in adults Long-term goals of this proposal are to (1) investigate the role of epigenetic programming in the presentation of alcohol-related malformations through detailed quantification of the craniofacial phenotype and (2) correlate genomic differences with these features to find epigenetically modified genes responsible for the phenotypic differences . In the future, these genes and the mechanism(s) by which they are modified in this model can be translated into clinical research and can offer the potential to find ways to better diagnose or even prevent or circumvent the negative effects of alcohol on fetal development. The role for epigenetic programming in alcohol-related phenotypes will be addressed through these specific aims: K1. To explore the effect of gestational alcohol exposure on embryonic craniofacial development: K2. To assess the impact of genetic variation on craniofacial development. R1. To characterize fetal craniofacial gene expression changes in response to gestational ethanol exposure R2. To explore the longitudinal effects of maternal alcohol consumption on post-natal craniofacial development R3. To develop a bioinformatics model infrastructure for making data and results from this proposal available. The University of Washington Schools of Medicine and Dentistry have over 1,800 full-time faculty members in 38 Departments, including 8 Nobel laureates. This year the UW Department of Pediatrics was ranked 6th by the US News and World Report among its peers.

Public health relevance
PROJECT NARRATIVE Fetal alcohol syndrome represents the most extreme consequence of maternal alcohol consumption and is of considerable health importance. The reasons for the highly variable outcomes from fetal exposure to ethanol are unknown. The uncertainty might be related to dose, time and duration of ethanol exposure as well as the influence of race, gender and maternal age. Understanding the factors impacting on craniofacial form is an essential step to improve diagnosis and management of fetal alcohol spectrum disorders, and will significantly aid the development of more effective educational programs pertaining to the adverse effects of maternal alcohol consumption on fetal and adult health. These factors will be explored using a unique animal model and strictly controlling the confounding variables such as environment, dosage and genetics. __SpecificAimsTextDelimiter__ SPECIFIC AIMS Perturbations of the fetal environment, such as malnutrition or stress, lead to permanent changes in the epigenome. These changes alter expression levels of 'sensitive' genes and developmental pathways and have long lasting effects on adult health including disease presentation. It has been known for a long time that in utero exposure of fetuses to alcohol results in a continuum of phenotypic features collectively termed "fetal alcohol spectrum disorders" or FASD. At present, the molecular events underlying FASD are unknown. We have developed a novel mouse model that demonstrates that chronic exposure of the fetus to physiologically relevant amounts of alcohol during the first half of pregnancy results in quantifiable craniofacial dysmorphology reminiscent of that seen in fetal alcohol syndrome, and that this is associated with epigenetic changes, ie. changes in DNA methylation and consequently gene expression. These exciting new data suggest that the long-term effects of alcohol exposure during pregnancy are mediated by epigenetic changes and that our unique model will be a valuable tool with which to dissect the underlying causes of FASD. It is envisaged that such epigenetic changes may ultimately be used as markers for preclinical diagnosis and treatment of FASD. My long-term goals are to (1) investigate the role of epigenetic programming in the presentation of alcohol- related malformations through detailed quantification of the craniofacial phenotype and (2) correlate genomic differences with these phenotypic features to find epigenetically modified genes responsible for the changes. The objective of this Award is to provide me with the requisite skills and data to quantify and visualize the phenotypes associated with FASD in mice, while I augment my background through formal study of embryology and quantitative genetics. I will use different mouse strains to understand the quantitative contributions of natural gene variants influencing craniofacial skeletal form and to test for variable sensitivity to the effects of alcohol. My central hypothesis is that alcohol related alterations in fetal programming leads to permanent changes in the epigenome and contributes to the presentation of FASD phenotypes, which can be correlated with changes in expression of key genes that govern normal craniofacial development and shape. This hypothesis is based on our prior evidence that ethanol exposure during gestation results in epigenetic modifications that can alter adult phenotypes. The rationale for my project is that, once phenotypes associated with FASD in mouse models are clearly established, studies aimed at identifying the epigenetically modified genes can be facilitated. In the future, these genes and the mechanism(s) by which they are modified in this model could be translated into clinical practice through better diagnostic power or approaches to prevent or negate the effects of alcohol on fetal development. I will investigate the role for epigenetic programming in alcohol-related phenotypes by addressing the following specific aims during K99 and R00 phases: AIM K1. To explore the effect of gestational alcohol on embryonic facial development: I will use optical projection tomography to image mouse embryos that are exposed to alcohol in utero and apply new geometric morphometric techniques in order to determine the quantitative phenotypic effects of ethanol on early craniofacial morphogenesis. I hypothesize that, compared to controls, the ethanol exposure groups will present different craniofacial phenotypes evident during early morphogenetic events in the embryo. AIM K2. To assess the impact of genetic variation on craniofacial development. I will quantitatively phenotype the craniofacial skeleton of five hundred 28 day old N2 offspring from a backcross between the C57Bl/6J and A/J strains of mice and use the various detectable craniofacial traits to map the location of responsible loci (ie. quantitative trait loci). I hypothesize that QTL intervals will be identified that contribute to various localized differences in craniofacial shape between the two strains and that these genomic regions harbor genes that represent candidate effectors of the epigenetic response to alcohol. AIM R1. To characterize fetal craniofacial gene expression changes in response to gestational ethanol exposure. I will use microarray analyses to compare the differences in craniofacial gene expression profiles between controls and exposure groups with the goal of identifying the epigenetically sensitive genes. The genomic location of each differentially expressed gene will be compared to the QTL intervals determined in Aim K2. Differentially expressed genes that map to QTL intervals specific for localized craniofacial form similar to that affected by maternal ethanol exposure will be identified for further functional studies. AIM R2. To explore the longitudinal effects of maternal alcohol consumption on post-natal craniofacial development of offspring: Using in vivo microCT imaging and quantitative phenotyping, I will document the changes in post-natal phenotypic growth following exposure to alcohol via maternal consumption. AIM R3. Develop a bioinformatics model infrastructure: I propose to build a publicly accessible portal through which data and information created during this project can be queried through a web interface for the benefit of the broader craniofacial research community.